BRAIN CONNECTS: A Scalable Automated Proofreading Framework for Connectomics

Summary
Generating synapse-resolution maps or connectomes of the brain are crucial to understanding the neural basis
of behavior, and can provide key insights into the onset, progression, and treatment of neurological disease and
injury. Towards this goal, major advances in electron microscopy imaging and automated image segmentation
have enabled researchers to produce millimeter-scale connectomic datasets, and forge a path towards an even
larger whole mouse brain volume. Despite the high quality of automated segmentation at this scale, the
enormous extent of axon and dendrite “wiring” in the brain unavoidably leads to errors in neuronal connectivity
that require correction with post-hoc proofreading. Although a variety of approaches have been developed to
enable faster manual proofreading, the number of human hours needed to correct errors are prohibitive, and
prevent us from realizing the full potential of valuable datasets such as the cubic millimeter MICrONS (mouse
cortex) and H01 (human cortex) volumes. To enable even larger connectomes, we must develop cost-effective
and time-saving automated methods to replace labor-intensive human proofreading where possible and allow
human resources to focus on other connectomic tasks that include generating training data and validating
automated correction. The goal of this proposal is to build capabilities for scalable automated proofreading,
leveraging and extending software tools built during our previous IARPA MICrONS activities: NEURD (short for
NEURal Decomposition), an automated error detection and correction framework built by Baylor College of
Medicine, and NeuVue, a scalable manual proofreading platform built by the Johns Hopkins University Applied
Physics Laboratory. Both tools are deeply integrated and complementary to the existing ecosystem of open-
source connectomics tools and resources from the community such as Neuroglancer, PyChunkedGraph (PCG),
and Connectomics Annotation Versioning Engine (CAVE). Building on the foundation of these tools and our
existing collaboration, we will add capabilities for machine learning enabled error detection of a wider range of
error types including both merge and split errors. We will implement an active learning approach that focuses
valuable human validation effort on the most informative error examples, with the goal of statistically validating
entire classes of edits that can be applied in automated batches to the segmentation. Finally, we will develop a
workflow for applying these automated edits to the segmentation in an optimized way that also does not conflict
with existing manual proofreading and retains a confidence metric for each edit that can be used for downstream
analysis. The successful completion of this project, “Connects-Proof: A Scalable Automated Proofreading
Framework for Connectomics” will yield a mature workflow that is validated across multiple data sets and that
can support existing and future work in the BRAIN-CONNECTS program.

Public health relevance
Project Narrative Despite the high performance of automated segmentation, substantial proofreading is required to correct reconstruction errors within large-scale connectomic datasets. To enable auto- corrections at scale in existing and emerging large datasets, we propose to develop “Connects- Proof, a scalable automated proofreading framework for connectomics”, that leverages, integrates, and extends software tools initially developed for the cubic millimeter MICrONS dataset: NEURD (short for NEURal Decomposition), an automated error detection and correction framework, and NeuVue, a scalable manual proofreading platform. Enabled by automated proofreading, accurate large-scale connectomes can provide unprecedented insights to understand brain function.